Data Management and Analysis Core

ABSTRACT
DMAC
The Data Management and Analysis Core (DMAC) of our NC State SRP Center proposal is designed to integrate
results from all data streams into a true synthesis that advances environmental and public health related to per-
and polyfluoroalkyl substances (PFAS). The first activity (Specific Aim) of the DMAC in establishing Center-wide
data management and integration was the development of a Comprehensive Data Management Plan (cDMP).
The cDMP was designed to instantiate FAIR (Findable, Accessible, Interoperable, Reusable) principles in
managing Center data and was used for the coordinated development of individual project/core DMPs. A key
element of our cDMP is the derivation of an ontology of data types, which recognizes that data have common
elements that cross disciplinary (as well as project-specific) boundaries. This formalization of connections
between nominally different data streams and assignment of individual points-of-contact for each type will
establish the DMAC as a resource for operationalizing data integration. Subsequent DMAC Specific Aims
establish processes for monitoring data analysis, coordinate analysis through shared data structures and
associated software, provide means for visualization and sharing of results, and coordinate data-centric training
activities. Thus, the DMAC will enable synthesis not possible from singular Projects/Cores alone, through
coordination amongst projects and cores, fostering data sharing and interoperability, and providing formal data
quality assurance and quality control.

Public health relevance
NARRATIVE DMAC The Data Management and Analysis Core (DMAC) will manage the integration of data streams generated by the Projects and Cores of the NC State Superfund Research Center. The DMAC aims lay out a data-centric approach to synthesize this multi-scale integration into actionable discoveries that advance public health related to per- and polyfluoroalkyl substances (PFAS). The translational impacts of DMAC will include new methods for tackling the interface between environmental chemical sampling and resultant public health consequences, distributed software to make these methods available to SRP teams addressing similar questions in other compound families, and promotion of computational fluency in the next generation of Environmental Health Scientists.